Core A: Administrative Core

PROJECT SUMMARY: CORE A
Core A is an essential component of this program project. Aim 1 emphasizes its role in initiating and organizing
regular communication between the principle investigators and personnel for each project and research service
core, with a goal to ensure each program element appropriately prioritizes and efficiently completes high-
impact research. In Aim 2, core A will ensure advisory boards provide sufficient program oversight, both with
respect to scientific activities, as well as ensuring the program follows NIH mandated policy on scientific
research. In aim 3, Core A will provide organization and logistical support for the program, including the
administration of all fiscal resources.

Public health relevance
NARRATIVE: CORE A Administration Core (Core A) ensures communication between all projects and cores, provides a mechanism for external and internal review, and provides logistical and administrative support.